Basic and Translational Mechanisms of Alloimmunization to RBC Transfusion. Project 2

RBC alloimmunization occurs when patients make antibodies to foreign antigens expressed on allogenic donor
RBCs, and remains a significant cause of morbidity and mortality among chronically transfused patients.
Though the vast majority of RBC transfusions express foreign antigens, only a subset of transfused patients
will make alloantibodies. Indeed, patients tend to stratify into those who make multiple alloantibodies
(responders) and those who never make an alloantibody despite multiple transfusions (non-responders).
However, the molecular factors that regulate responder vs. non-responder status are poorly defined. RBCs
have long been known to secrete of ATP and regulate endothelial cell function via resultant purinergic
signaling, but the impact of purinergic signaling on RBC alloimmunization has not been previously addressed.
We hypothesize that RBC driven purinergic signaling tends to suppress the antibody response to transfused
RBCs, and further that inherent differences in purinergic signaling sensitivities among patients can impact their
responder status. Using a mouse model of RBC alloimmunization, our preliminary data demonstrate that
multiple different steps in the purinergic signaling pathway (P2X7R, CD73, and ADORA2b) do indeed regulate
anti-RBC alloantibody production. This proposal sets out to determine the exact cellular and molecular
mechanisms by which purinergic signaling regulates RBC alloimmunization, and further determine whether the
known gain and loss of function polymorphisms of purinergic receptors can dictate whether a given patient will
make anti-RBC IgG alloantibodies. Specifically, Aim1 of our proposal will test the hypothesis that B cell binding
to transfused RBCs induces PANX1 mediated ATP secretion, and this extracellular ATP drives P2X7R
activation. We further hypothesize that P2X7R activation suppresses IgG class-switching and germinal center
formation by inducing ectodomain shedding of key B cell surface proteins. Aim2 of our proposal will test the
hypothesis that CD73 expression on B cells regulates the balance of AMP and Adenosine signaling on
responding B cells, ultimately altering B cells responses by regulating intracellular cyclic-AMP signaling.
Finally, Aim3 of this proposal will test the hypothesis that known polymorphisms in the P2X7R, ADORA1 and
ADORA2b genes can account for some of the phenotypic differences observed among responder and non-
responder patient populations. Synergy between projects comes from crosstalk between our focus on
purinergic signaling and (a) the known interactions between P2X7R signaling and immune complex signaling
through TLR7 and TLR9 (Project 1), (b) the fact that P2X7R is highly expresses on RBC precursors but
decreases as RBCs mature (Project 3), and (c) the known enhancement of soluble CD73 and increased levels
of ATP, ADP, AMP and Adenosine in patients with sickle cell disease (Project 4).